The role of breast stem cells in breast cancer etiology and risk prediction

Background and Objectives: Breast tissue is dynamic and undergoes significant structural changes
throughout a woman's life. The breast tissue architecture is maintained by a population of stem cells with self-
renewal capacity which are essential for tissue repair and remodeling. Recently, the role of stem cells in breast
carcinogenesis has been recognized as a high priority for translational breast cancer research. The stem cell
hypothesis of breast carcinogenesis suggests that breast cancer development might be directly related to the
size of the stem cell pool and its mitotic activity. Further, in the mammary gland stem cells are the only cell
subpopulation that has capacity to accumulate all the oncogenic alterations. The proposed R01 project will fill
the gaps in our understanding of the role of stem cells in breast carcinogenesis and their interplay with breast
cancer risk factors and pathways. Specifically, using prospectively collected data and samples within Nurses'
Health Study and Nurses' Health Study II cohorts, we will explore: 1) the prospective associations of parity,
age at first birth, birthweight, and adolescent body size with CD44, CD24, and ALDH1A1 stem cell markers
(n=1,348); 2) the association between stem cell markers in benign breast biopsies and subsequent breast
cancer risk (~190 breast cancer cases/575 controls); and 3) the prospective associations of pre-biopsy
circulating IGF-1 and IGFBP-3 (n= 472) with stem cell markers in subsequent benign biopsy samples.
Methods: We will utilize an incident benign breast disease (BBD) study and a nested breast cancer case-
control study within these cohorts to address the study aims. All BBD diagnoses are being confirmed with
central pathology review. Some tissue microarrays (TMAs) from benign biopsies have been constructed in
these cohorts, and additional TMAs will be added during the project period. Stem cell markers will be stained
with commercially available antibodies using immunohistochemistry (IHC), and the staining results will be
evaluated with automated image analysis. Information on plasma IGF-1 and IGFBP-3 is available from
previous studies within these cohorts. Breast cancer risk factor data have been collected at baseline and
updated biennially. Significance: We propose a highly novel investigation that will comprehensively examine
the role of stem cell markers in breast carcinogenesis. The study aims to shed light on molecular pathways
behind the observed associations of breast cancer risk factors with breast cancer risk as well as to identify
markers that could advance future risk prediction in a large segment of high-risk women undergoing routine
breast biopsies which could pave the way for novel personalized breast cancer prevention and surveillance
strategies. The results will also add to the limited evidence on the association of IGF pathway with expression
of breast stem cell markers. As stem cell activity is potentially modifiable via a variety of targeted therapies, the
findings could translate into stem cell-directed pharmaceutical interventions aimed at breast cancer risk
reduction in high-risk women with BBD in whom novel prevention strategies are urgently needed.

Public health relevance
PROJECT NARRATIVE Throughout a woman's life, the breast tissue structure is maintained by a population of so-called stem cells with self-renewal capacity; these cells have also been linked to unfavorable tumor characteristics and poorer breast cancer outcomes. We propose a highly novel investigation that will comprehensively examine the role of stem cells in development of breast tumors. The study will shed light on associations of the breast stem cells with various breast cancer risk factors and will explore how specific markers in these stem cells could be used to improve breast cancer risk prediction in a large segment of high-risk women undergoing routine breast biopsies which could pave a way for novel personalized breast cancer prevention and surveillance strategies.